INTRAVENOUS AND ORAL DOSAGE OF INDOLIDAN IN HEART FAILURE

The purpose of this study is to define the role of phosphodiesterase inhibitors in the medical management of CHF and the hemodynamic response to an intravenous dose.